Linking Variants to Multi-scale Phenotypes via a Synthesis of Subnetwork Inference and Deep Learning

Project Summary
The ability to accurately predict the effect of genetic variation on phenotypes at multiple scales would radically
transform our ability to apply genomic technologies in order to understand human health and disease. This
predictive ability would significantly improve the effectiveness of a broad spectrum of genomic analyses
ranging from genome-wide association studies for common diseases to diagnostic odysseys searching for
genetic causes of rare diseases.
To address this challenge, we propose to develop a trainable approach for predicting the phenotypic impact of
genetic variants. This approach will support predictions for a broad range of genetic variations, phenotypes,
and biological contexts. It will incorporate and exploit mechanistic knowledge of pathways where available, but
augment this pathway knowledge with learned models where it is not. This approach will consist of a synthesis
of (i) methods that link genomic variants to their effect on expression or function of individual gene products, (ii)
methods that link those relationships into the subnetworks involved in cellular responses of interest, (iii)
machine-learning approaches that infer models pertaining to a variety of genotype-phenotype relations from
large training sets.
We will also develop and apply active learning algorithms to identify the most informative experiments for
subsequent analysis by IGVF Consortium. Additionally, we will develop and apply a statistical framework for
elucidating genetic modifiers, through probabilistic, network-informed inference of common variants identified
in GWAS that modify the impact of rare variants implicated in sequencing-based association studies.
Throughout the project, we will work closely with other IGVF Centers to guide experimental data collection,
benchmark methods from across Centers, and contribute to the variant-element-phenotype catalog which will
have broad applications by the community.

Public health relevance
Narrative Being able to characterize the impact of genetic variants on phenotypes is critical for interpreting the roles these variants play in human health and disease. The proposed research will significantly advance our ability to predict the impact of genetic variants thereby boosting the effectiveness of genomic analyses ranging from genome-wide association studies for common diseases to diagnostic odysseys searching for genetic causes of rare diseases.